Social experience dependent modification of gene regulation and circuit function

RESEARCH STRATEGY
NIGMS administrative equipment supplement for Parent Award R01GM146010 (NOT-GM-22-017):
PI: Pelin C. Volkan - Social experience-dependent modification of gene regulation and circuit function
Animals modulate their social behaviors in response to both internal and GH CS♂ SH CS♂
environmental signals to increase fitness. The molecular and neural circuit-based
mechanisms underlying behavioral regulation in response to sensory cues remain
unclear. The parent award addresses the role of social experience in modulating gene Canton S ☿ w1118☿
expression, circuit function, and courtship behaviors in D. melanogaster. In D.
melanogaster, FruitlessM (FruM) and DoublesexM (DsxM) are critical transcription factors
that control male-specific innate and learned courtship behaviors, respectively [1-3].
Socially experience alters male courtship in both wild-type and fru mutants, as well as GH SH 1. GH SH
Figure Males
modifying fru transcription and chromatin state [4-7]. The awarded proposal monosexually grouped or
CS w1118
identify social experience and pheromone signaling-dependent changes in
15
10
around fru and 2) dsx genes, and 3) determine their effects on downstream t
5
expression, circuit function, and behavioral outputs.
0
15
Scientific Justification for Requested Supplement Equipment: 10
5
All objectives of the parent award R01GM146010 necessitate quantitati 0
responses from P1 courtship command neurons in the central brain. To
0.00 0.25 0.50 0. 0.00 0.25 0.50 0.75 1.00 0.00 0.25 0.50 0.75 1.00 0.00 0.25 0.50
Courtship Index
Courtship index
Canton S ☿ w1118 ☿
15is
10
a
5
e
0
w
fl s i
olated for 7
ssayed for co
ther Canton-S
female Iso a
days before
urtship with er”
female or
ed Canton GH

“ Non-courter” “Court

ie
of

1 11 8
. l

t
-
ber
15
C
1
0
u
m
S
males court
anton-S and w1 more with
females. SH
N 1 18
0
5

requesting funds to purchase the Bruker Ultima Investigator Plus Laser Scanning microscope with a Coherent
AXON 920-2 TPC laser to support the parent award 5R01GM146010. Aligned with the goals of the parent
proposal, we found that social isolation increases the activity
of P1 courtship command neurons and courtship behaviors, AA B
as well as altering the transcriptional and chromatin state of
fru, dsx, and other neuromodulatory genes in the brain. To
causally link the effects of socially regulated genes on
courtship circuit activity, all aims depend on 2-photon imaging
of courtship command neurons in genetic and functional
manipulation of distinct genes and neurons within the
C D
courtship circuits. Bruker Ultima Investigator Plus Laser
Scanning microscope with a Coherent AXON 920-2 TPC
laser will allow the detection, resolution, and quantitative
analysis of calcium dynamics of critical neurons in the
courtship circuits, in response to different social contexts as Figure 2. A) P1 Courtship command neuron dendritic field for
calcium recording. B) 2-photon microscopy set up for live
well as genetic and functional manipulation. The analyses with calcium imaging. C) Live GCaMP imaging of P1 courtship
this system will significantly improve the impact of all the aims command neurons show elevated calcium activity in single
housed male brains compared to group housed male brains.
of the funded proposal and are necessary for the success of Graph in D) shows quantification of GCaMP signal.
the project.
My team visited Nilay Yapici's laboratory at Cornell University to learn the 2-photon setup, male brain
preparation, and live imaging. Initially, we utilized a Leica DIVE SP2 multiphoton system housed in the Duke
Light Microscopy Core Facility, which is shared by multiple labs on campus. However, limited access to the
microscope and the high associated cost make this unsustainable for essential optimization procedures and
experiments of the required scale and duration. This presents a significant delay and financial challenge for
successfully conducting and troubleshooting the necessary experiments within the current budget constraints of
Count
CS fru 440/lexA Or47b 2/3 Or67d GAL4
fru
dsx
FoxP
Dsk
CCKLR17D3
GH SH GH SH GH SH GH SH
Figure 3. Transcriptional responses of of
some courtship regulatory genes are shown
for grouped (GH) and isolated (SH) male
brains from wild type (CS), Or47b, Or67d
and fru mutants.
the parent grant. Acquiring the Ultima Investigator Plus Laser Scanning
Microscope system with a Coherent AXON 920-2 TPC laser will overcome
cost and access limitations. Additionally, it will enable computational
synchronization of infrared videos capturing the male's detection of the
female, triggering P1 GCaMP responses— a feature currently lacking in the
Core Facility's Leica DIVE SP2 system. In summary, the purchase of the
new system will significantly enhance our ability to record neural responses,
overcoming crucial limitations and ensuring the successful completion of
the project.
A key goal of Aim 1 is to identify changes in fru gene regulation by social experience and pheromone signaling
and its effects on courtship circuit function and behavioral outputs. Social isolation
increases activity in P1 courtship command neurons in the central brain, resulting
in heightened courtship behaviors toward females (Figs. 1 and 2). We found that
both fru and dsx show a general upregulation in gene expression in socially
isolated male brains (Fig. 3). However, single-cell RNAseq analysis from fru-
positive neurons in the central brain reveals only a few clusters where fru
expression is significantly influenced by social isolation (Fig. 4). To establish a
causal link between fru regulation and neural activity, we plan to conduct
knockdown or overexpression of fruM in neural clusters regulated by social
experience and assess their effects on P1 neuron activity and courtship in
grouped and isolated males.
Our investigation into courtship behaviors in pheromone receptor mutants
revealed the involvement of neural circuits activated by Or47b neurons in
suppressing courtship after group housing (Fig. 5). To establish a causal link
between Or47b neural circuits and the modulation of courtship with social
experience, we aim to record GCaMP responses from P1 neurons in grouped and
isolated wild-type and Or47b mutant male brains. We will also examine males with Figure 4ed. Dot plot showing
GH/SH log2fold change of some
either activated or silenced Or47b neurons. Given the crucial role of P1 neurons differentially expressed genes in
in initiating courtship, live imaging of GCaMP responses is critical and requires different fru-positive neural clusters.
Many of these genes have known
unlimited access to a two-photon microscope system. The Ultima Investigator functions in modulating courtship.
Plus Laser Scanning Microscope system with Coherent AXON 920-2 TPC laser, GO:0008049 (male courtship behaviors)
provides the necessary equipment for this investigation.
A key goal of Aim 2 is to identify changes in dsx gene regulation by social experience in wild type, fru and
pheromone receptor mutants and its effects on courtship circuit function and behavioral outputs. Isolated fru
mutants display no courtship, yet they learn to court when grouped with other Male-Female courtship
flies [5]. Interestingly, fru-dsx double mutants do not exhibit social experience-
dependent courtship learning [5]. We propose that social experience-
dependent transcriptional changes in fru mutants influence P1 neural activity
and courtship responses. Compared to wild-type males, fru mutants exhibit
increased dsx expression in grouped males and decreased expression in
isolation (Fig. 3). Additionally, we've identified socially regulated
neuromodulatory genes in wild-type and fru mutant brains (Fig. 3 and 4). We GH SH GH SH GH SH
are currently screening courtship in double mutants of fru-dsx, Or47b- fru, and CS Or47b 2/3 Or67d GAL4
Or67d-fru to pinpoint pheromone circuits driving differential transcriptional Figure 5. GH index in wild
Courtship (CI)
type (CS), Or47b and Or67d mutants
responses of dsx to social context. To establish causal links between socially that are grouped (GH) and isolated (SH).
regulated genes (e.g., dsx) and circuit responses, we will utilize the Ultima
Investigator Plus Laser Scanning Microscope system to record P1 neuron GCaMP responses in grouped and
isolated wild-type and fru mutant males, as well as fru mutants where candidate genes are genetically
manipulated.
A key goal of Aim 3 is to identify changes in transcriptional profiles in the central brain in response to social
experience, pheromone signaling and FruM function, and their effect on courtship and courtship circuit activity.
Our recent RNAseq experiments revealed differential expression in genes related to courtship regulation,
synaptic plasticity, learning/memory, and neuromodulation in response to social experience and pheromone
circuit activity (Figs. 3 and 4) [8]. To establish causal links between gene expression modulation and neural
circuit activity regulated by social experience and pheromone circuit function, we plan to record GCaMP
responses in P1 courtship command neurons through various genetic experiments. This will enable the
establishment of causal links between genes transcriptionally regulated by social experience and pheromone
circuits, shedding light on the modulation of circuit and behavioral function. These experiments necessitate the
use of the Ultima Investigator Plus Laser Scanning Microscope system with Coherent AXON 920-2 TPC laser.
Anticipated future costs and training with the requested equipment:
The initial training cost is incorporated into the Bruker Ultima Investigator Plus Laser Scanning microscope
system. Bruker will provide ongoing service for the scope at no cost, eliminating upkeep expenses. Any additional
maintenance issues will be addressed using available discretionary funds and funds from the parent grant.
Pka-C1 S S h hab
D d o n p c 1R1 mGluR Rdl rut sb
Dop1R2 Kl
AGO1 FoxP fru
cac

Public health relevance
PROJECT NARRATIVE: Results from the proposed study are expected to provide fundamental knowledge on the role of sensory experience-mediated changes in chromatin and gene expression in flexible behavior. The proposed experiments will identify basic epigenetic, molecular, and circuit principles by which the environment induces changes in gene expression to alter the function of an individual or ensemble of neurons within a circuit and ultimately modify organismal behaviors. Thus, our findings may lead to novel and cheaper sensory experience-based therapeutic strategies that harness similar types of plasticity against psychiatric disorders, such as autism spectrum disorders, and depressive and anxiety disorders, where misprocessing of sensory information accentuates anxiety and social behaviors.